Promoting Adherence to Sleep Apnea Treatment among Blacks with Metabolic Syndrome

DESCRIPTION (provided by the applicant): Despite the availability of evidence-based treatment models for sleep apnea, the majority of at-risk individuals in underserved US communities remains undiagnosed. This is a major public health concern since untreated sleep apnea is linked to cardiovascular disease and components of the metabolic syndrome. Blacks endorse a disproportionate burden of sleep apnea-related morbidity. Yet, few black patients adhere to recommended sleep apnea assessment by their physician, while most referred patients receive a diagnosis of sleep apnea. Maximizing the likelihood that black patients adhere to physician recommended sleep apnea assessment and treatment, thus reducing cardio-metabolic morbidity, is the focus of this proposal. The aims are consistent with NIH program announcement (RFA-MD-09-004), soliciting proposals to study chronic diseases that disproportionately affect underserved, and low-income ethnic minorities. In a two-arm randomized controlled trial, we will assess effectiveness of a culturally and linguistically tailored telephone intervention in increasing adherence to recommended assessment and treatment of sleep apnea. Telephone interventions will be delivered by trained, quality-controlled Health Educators. The sampling frame will consist of 340 black patients enrolled in the Metabolic Syndrome Outcome Study (MetSOS), a Brooklyn-based study of patients with cardio-metabolic diseases. Among patients with metabolic syndrome and are at high risk for sleep apnea, those randomized to the intervention arm, compared with those randomized to the attention-control arm, will have: 1) greater adherence to physician recommended sleep apnea assessment at 6 months and 2) greater adherence to treatment with Continuous Positive Airway Pressure post diagnosis; 3) effects of the intervention on adherence rates will be sustained 6 months after discontinuing active interventions, and treatment will improve components of the metabolic syndrome (waist circumference, blood pressure, lipid level, and fasting plasma glucose; and 4) patients' knowledge about sleep, self-efficacy, readiness, trust/rapport with the Health Educator will mediate intervention effects on study outcomes. We expect that our intervention will serve as an alternative model of promoting awareness of sleep apnea and enhancing adherence to recommended care among blacks nationwide.

Public health relevance
Project Narrative This proposal will test the effectiveness of a tailored telephone intervention in increasing adherence to recommended sleep apnea assessment and treatment among black patients at high risk for sleep apnea. The sampling frame will consist of 340 patients enrolled in the Metabolic Syndrome Outcome Study, a Brooklyn-based study of patients with cardio-metabolic diseases. We expect that our intervention will serve as an alternative model of promoting awareness of sleep apnea and enhancing adherence to recommended care among blacks nationwide. __SpecificAimsTextDelimiter__ Promoting Adherence to Sleep Apnea Treatment among Blacks with Metabolic Syndrome A. SPECIFIC AIMS Despite the availability of evidence-based treatment models for sleep apnea, the majority of at-risk individuals in underserved communities remains undiagnosed.2-4 This is a major public health concern since untreated sleep apnea is linked to cardiovascular disease5-9 and components of the metabolic syndrome including obesity,10 hypertension,11 diabetes,11 and dyslipidemia.12 Blacks have a disproportionately greater burden of sleep apnea-related morbidity compared with whites.13 Yet, preliminary evidence from community-based practices in Brooklyn, NY indicated that only 38% of black patients adhered to recommended sleep apnea assessment, while 91% received a polysomnographic diagnosis of sleep apnea.14 Thus, the aims of this proposal are consistent with NIH program announcement (RFA-MD-09-004), soliciting proposals to study chronic diseases that disproportionately affect underserved, low-income ethnic minorities. In a two-arm randomized controlled trial, we will assess the effectiveness of a culturally and linguistically tailored telephone intervention in improving adherence to assessment and treatment of sleep apnea in black patients. Trained Health Educators will deliver telephone interventions. The sampling frame will consist of 340 black patients enrolled in the Metabolic Syndrome Outcome Study (MetSOS), a Brooklyn-based study of patients with cardio-metabolic diseases. The multidisciplinary investigative team is well positioned to execute the study. Dr. Jean-Louis, the PI, is a LRP Minority Scholar and a behavioral sleep specialist with 10 years of experience working with minorities. The Co-Investigators, Drs. Ogedegbe (a clinical epidemiologist, internist and behavioral scientist), Brown (a lipidologist and nephrologist), and McFarlane (an endocrinologist and diabetes specialist) have excellent track records conducting minority research and providing care to minority patients with metabolic diseases. There is strong institutional commitment to the proposed study. Last year, SUNY Downstate Medical Center launched a sleep-disorders center in a centralized Brooklyn community, providing easy access to sleep health providers. Primary aim: To evaluate effect of a culturally and linguistically tailored, telephone-delivered behavioral intervention, versus an attention-control condition, on adherence to recommended assessment and treatment of sleep apnea. Secondary aims: 1) To evaluate the maintenance of intervention effects on adherence 6 months post- intervention; and 2) To assess treatment effects on components of the metabolic syndrome (waist circumference, blood pressure, lipid level, and fasting plasma glucose/HbA1C). Exploratory aim: To identify the mediators of adherence to recommended sleep apnea assessment and treatment following exposure to the intervention. Hypotheses: Among patients with metabolic syndrome and are at high risk for sleep apnea, those randomized to the intervention arm, compared with those randomized to the attention-control arm, will have: Hyp. 1: Greater adherence to physician recommended polysomnographic sleep apnea assessment15 at 6 months. Hyp. 2: Greater adherence to treatment with Continuous Positive Airway Pressure.15 Hyp. 3: Effects of the intervention on adherence rates will be maintained 6 months after discontinuing active interventions, and this treatment will improve components of the metabolic syndrome. Hyp. 4: Patients' knowledge about sleep, self-efficacy, readiness, trust/rapport with the Health Educator will mediate intervention effects on study outcomes. Public health significance and long-term goal: This intervention will test a tailored intervention aimed at increasing utilization of available sleep apnea services in an underserved, low-income population, thereby achieving goals of Healthy People 2010.16 It is predicated upon preliminary evidence that adherence to recommended sleep apnea assessment among blacks is low. As such, successful completion of this project will provide empirical evidence supporting utilization of tailored telephone interventions as a proven instrument to promote awareness of sleep apnea and enhance adherence to recommended care in this high-risk population. The long-term goal is to apply this tailored intervention in at-risk minority populations as an alternative model of promoting awareness of sleep apnea and enhancing adherence to recommended care among blacks nationwide.